Center for Latino Health Research Opportunities-CLaRO - Administrative Core

Revised Abstract Section

ABSTRACT

The Administrative Core of the proposed Center for Latino Health Research Opportunities (CLaRO) will oversee and direct the infrastructure and collaborative community-engaged research and investigator development activities of the Center. Within the innovative cross-institutional partnership between University of Miami (UM) and Florida International University (FIU), CLaRO’s Administrative Core will facilitate coordination, integration, and collaboration across all activities of the Investigator Development Core (IDc) and Community Engagement and Dissemination Core (CEDc), including the CEDc Community/Scientific Advisory Board and early-stage investigators (ESI) who participate in CLaRO training activities. Additionally, the Administrative Core will collaborate with institutional and community partners and NIMHD to accomplish CLaRO’s overarching goals; the Administrative Core will also lead CLaRO in leveraging the research and training infrastructure UM and FIU, and associated NIH-funded centers, institutes, and programs, to further develop the health disparities scientific workforce. The Administrative Core will ensure that CLaRO activities align with the Center’s theme, advancing strategies in implementation science to reduce health disparities in substance abuse, violence/trauma, HIV/AIDS, and mental health (SAVA+MH) in the Latino community in Miami-Dade County, Florida. The Administrative Core has the following Specific Aims: Aim 1. Coordinate career enhancement activities to facilitate research and investigator development related to the CLaRO theme. The Administrative Core will coordinate the Pilot Projects Program and Research Enhancement Program as detailed in the IDc Research Strategy. This Core’s role in IDc activities will consist of (1) administration, including fiscal and logistical support, and (2) coordination of these activities within CLaRO and with other programs and resources at UM and FIU. Aim 2. Coordinate Community Engagement/Dissemination of activities related to Investigator Development Core. This will include: (1) Coordination of all meetings (e.g., CSAB meetings), including fiscal and logistical aspects, and activities between individual CSAB members involvement in awarded Pilot Projects, (2) facilitating meetings and activities that will lead to the effective dissemination of Pilot Project research findings that engage community members, partnering organizations, service providers, and other key community stakeholders, (3) coordinating dissemination to and access of the CSAB and other community stakeholders to facilitate their participation in CLaRO Research Enhancement Program activities. The Administrative Core will guide CSAB members and other key community stakeholders affiliated to CLaRO in accessing the rich set of research resources available through CLaRO, our institutions, and our partnering centers/institutes. This includes providing technical assistance to CSAB members and Pilot Awardees in accessing social media resources and networks available at UM and FIU that will facilitate dissemination efforts.